Regulatory mechanisms and role of the PI3K-TSC-mTOR signaling network in tumors

DESCRIPTION (provided by applicant): The delineation of complex signaling pathways and networks is providing therapeutic targets and strategies for cancer and greatly enhancing our ability to predict and interpret clinical outcomes. The pathways involving the lipid kinase PI3K and the protein kinase mTOR are intimately linked in a cellular network, referred to here as the PI3K-TSC-mTOR network, that is comprised of numerous oncogenes and tumor suppressors. Dysregulation of this signaling network occurs in the majority of genetic tumor syndromes, such as tuberous sclerosis complex (TSC), neurofibromatosis, and Cowden disease, and all of the most common forms of cancer. Research under the original grant and continued in this renewal is revealing the molecular wiring of this signaling network in normal and tumor cells and providing novel insights into tumor development, progression, and therapeutic intervention. Progress: Research during the first 3.5 years of the original 4-year grant has yielded several new breakthroughs in our understanding of feedback regulation and other critical control points within the PI3K-TSC-mTOR network, and these have been reported and discussed in 14 publications during this time. Of particular significance for this renewal were discoveries regarding the two functionally distinct mTOR complexes (mTORC1 and 2), which provided some of the first insights into the regulatory mechanisms controlling mTORC2 activity. Current Direction: The aims of the original grant were geared toward understanding signaling mechanisms and their effects in cell and tumor models of the TSC disease. While our intense interest in TSC continues, in this renewal we will also expand on these findings to understand the role of this signaling network in human malignancies. Given the nearly universal corruption of the PI3K-TSC-mTOR network in glioblastoma, Aim 3 is dedicated to defining the mechanisms leading to its misregulation and their consequences in these aggressive tumors. In contrast to our detailed understanding of mTORC1, we know very little regarding the regulatory mechanisms and functions of mTORC2. Therefore, building on our recent discoveries with mTORC2 and the increasing evidence that it plays a key role in promoting tumorigenesis, the aims of this renewal are focused on the mechanisms of mTORC2 regulation in normal cells and misregulation in tumors. The specific aims use a variety of cell and mouse tumor models, as well as clinical samples, and involve several key collaborators. Specific Aims: 1) To determine the mechanisms and consequences of our recent surprising finding that the TSC tumor suppressors, while inhibiting mTORC1, activate mTORC2. 2) To determine the molecular mechanisms leading to mTORC2 activation downstream of receptor tyrosine kinases. 3) To determine the role of mTORC2 activation and downstream signaling in glioblastoma.

Public health relevance
This project will provide a detailed molecular understanding of the signaling network involving the tuberous sclerosis complex (TSC) tumor suppressors and the mammalian target of rapamycin (mTOR). These studies are critical to our understanding and treatment of the TSC disease, which is a genetic tumor syndrome, and a wide variety of human diseases in which defects in the control of mTOR have been implicated, including sporadic cancers, type-2 diabetes, and autism. Under this proposal, a particular emphasis will be put on the role of this signaling network in the development, progression, and treatment of glioblastoma.